The Mechanistic Role of Gut Microbes and Gluten in Alopecia Areata

Project Summary
Alopecia Areata (AA) is a chronic autoimmune disease of the hair follicle (HF) that results in hair loss. While the
exact cause of AA is unknown, genetic predisposition and environmental triggers might play important roles in
the disease. Recent studies suggest that dietary gluten, a known trigger in celiac disease (CD), may exacerbate
autoimmune responses in AA, particularly in individuals with gluten sensitivity or CD. However, the precise role
of gluten in the onset and progression of AA remains unknown. This project aims to fill this critical knowledge
gap by investigating how dietary gluten, through its impact on the gut microbiome, influences autoimmune
responses in AA. This research aligns with the mission of the NIAMS by contributing to a better understanding
of immune-mediated diseases and informing the development of more effective and safer therapeutic strategies.
The long-term goal of this study is to improve the management of AA by investigating how gluten
consumption and the gut microbiome contribute to disease progression. The research aims to uncover the
relationship between dietary gluten, gut dysbiosis, and immune system activation, potentially leading to novel,
personalized interventions such as dietary modifications and microbiome-targeted therapies. The study focuses
on two key objectives: Aim 1: Investigate how gluten-induced gut dysbiosis affects gut permeability and promotes
immune activation, which drives AA. Aim 2: Explore how gluten metabolism by specific gut bacteria, such as
Ligilactobacillus murinus (L. murinus), generates immunogenic peptides that activate CD8+ T cells, contributing
to AA progression. This research will use well-established mouse models of AA to investigate gluten’s impact on
gut health and immune function. The experimental approach includes: (1). Gut microbiome analysis: We will use
16S rRNA sequencing and shotgun metagenomics to profile gut microbiota changes in AA mouse models due
to gluten consumption. (2). Gut permeability and immune activation: We will assess changes in gut permeability
using FITC-dextran assays and examine pro-inflammatory cytokines and CD8+ T cell activation to link gut
dysbiosis with immune responses in AA. (3). Bacterial gluten metabolism: We will investigate how L. murinus
metabolizes gluten into immunogenic peptides, influencing AA progression.
This research will address a critical gap by exploring the link between dietary gluten and autoimmune
disease. If successful, it could lead to personalized dietary interventions and microbiome-based therapies,
offering effective alternatives to immunosuppressive treatments and transforming the management of AA and
other autoimmune conditions.

Public health relevance
Project Narrative Alopecia Areata (AA) is a prevalent dermatological disorder. This project seeks to investigate the mechanisms of gluten-induced gut dysbiosis and its role in immune dysregulation in AA. We aim to identify innovative therapeutic strategies to enhance the management of AA.